Enkephalin-mediated hippocampal circuit disinhibition after traumatic brain injury

Background and Innovation:
Post-traumatic epilepsy is a potentially devastating consequence of head injury in Veterans that is often
resistant to medical treatment. Post-traumatic epilepsy is associated with numerous functional changes in the
hippocampus, a region of the brain that is frequently the focal point for the initiation of seizures. Understanding
how these rearranged circuit elements contribute to brain hyperexcitability is critical to the development of
approaches to improve the treatment of Veterans with epilepsy.
One hippocampal circuit alteration noted in epilepsy is dramatic activity-dependent upregulation of the
endogenous opioid peptide enkephalin by hippocampal granule cell neurons. Although this phenomenon was
originally described in the 1980s, the functional roles of enkephalin-mediated signaling in the hippocampus
were not examined at the time due to technical limitations. Our preliminary experiments demonstrate that
enkephalin potently blocks inhibitory synaptic function in both the dentate gyrus and region CA3 of the
hippocampus. Additionally, our data demonstrate that both neuronal activity and traumatic brain injury (TBI)
dramatically upregulate enkephalin expression in the hippocampus. We hypothesize that the activity-
dependent increase in enkephalin directly contributes to brain hyperexcitability and post-TBI epilepsy.
In this proposal, we will define the impact of activity-associated upregulation of enkephalinergic
neurotransmission using translational seizure and TBI modeling in genetically modified mice. Our innovative
approach involves electrophysiological and novel opioid biosensor assays to advance our understanding of
how activity-dependent enkephalin upregulation affects hippocampal function, and how this contributes to
learning deficits and epilepsy after TBI. Additionally, we will use a novel activity-dependent enkephalin gene
deletion strategy to facilitate a series of experiments aimed at establishing a translational rationale to reduce
seizures and improve outcomes after TBI.
Significance and Impact to Veterans Healthcare:
Veterans with a history severe TBI have a 50% likelihood of developing post-traumatic epilepsy in the
years after their injury, and this is a debilitating, lifelong condition that is difficult to treat. If our work identifies a
brain circuit alteration that worsens outcomes after TBI, it will allow for the development of more effective
treatments for post-traumatic epilepsy that will have a major benefit on Veterans’ health. As endogenous opioid
signaling pathways also control many aspects of behavior beyond the hippocampus, our study is likely to
provide additional insights into endogenous opioid signaling that could have implications for increasing our
understanding of pain, addiction, and motivated behavior.
Path to Translation/Implementation:
Our study begins with mechanistic investigations and proceeds through proof-of-concept studies to
explicitly determine how the phenomenon of activity-dependent enkephalin upregulation contributes to post-
TBI epilepsy. If successful, our next steps will be to develop a more explicit understanding of the molecular
pathway sustaining enkephalin expression after TBI, and whether interference with this pathway in mouse
models has therapeutic benefit. This will then provide a therapeutic rationale and targetable pathway for the
development of treatments for Veterans with post-TBI epilepsy.

Public health relevance
Veterans recovering from traumatic brain injury (TBI) frequently develop epilepsy, and acquired epilepsy accounts for up to 50% of symptomatic epilepsy nationwide. Mechanisms underlying the development of epilepsy after TBI are unclear, but human and animal studies suggest that it involves functional changes in neuronal circuits in the hippocampal region of the brain. Strong episodes of neuronal activity in the hippocampus, which occur during TBI, drive upregulation of the opioid peptide enkephalin, but the functional consequences of this phenomenon have never been explored. Our data indicate that enkephalin potently depresses inhibitory network function in the hippocampus. In this proposal, we will use genetically modified mice and physiological assays to define how the activity-dependent upregulation of enkephalin affects circuit hyperexcitability and seizures in a mouse model of post-traumatic epilepsy. Through this work, we hope to eventually design therapies to prevent and treat post-traumatic epilepsy.